Germ cell specification and differentiation in planarians

Project Summary/Abstract
Germ cells give rise to gametes–oocytes and sperm–that fuse to create a totipotent zygote, which divides and
generates all the cells of an organism. During development, a new germ cell lineage must be established and
differentiate properly to ensure propagation of the species. Defects in germ cell development can lead to
infertility or germ cell tumors; furthermore, many cancers are associated with mis-expression of germ cell
genes. Much knowledge of germ cell development comes from model organisms in which maternal
determinants specify germ cells early in embryogenesis. By contrast, many animals (including mammals)
specify their germ cells in response to inductive cues from surrounding cells later in development. Despite
these differences, proper development of all germ cells relies on extrinsic factors provided by somatic support
cells, which act as a niche. The free-living planarian flatworm, Schmidtea mediterranea, is well known for its
extraordinary regenerative prowess based upon a population of pluripotent somatic stem cells. Strikingly,
planarians can regenerate new germ cells de novo from their somatic stem cells. Recent work has identified b-
alanyl-tryptamine (BATT) as a critical, niche-derived signal that triggers planarian germ cell development. This
dipeptide is the product of a nonribosomal peptide synthetase that conjugates b-alanine to tryptamine
(produced by decarboxylating tryptophan). Tryptophan, an essential amino acid, is taken up by the intestine; b-
alanine synthetic enzymes are also expressed in the gut. However, the nonribosomal peptide synthetase that
produces BATT is expressed in somatic gonadal cells. Thus, BATT may serve to integrate nutritional status
and reproductive maturation. To test this hypothesis, the following two aims are proposed: (i) to characterize
BATT production in somatic gonadal cells; and (ii) to identify the BATT receptor(s). In Aim 1, mass
spectrometry-based metabolic profiling will measure changes in b-alanine and tryptophan metabolism during
reproductive system development. Spatial transcriptomics will map the expression patterns of candidate genes
involved in the synthesis, metabolism, or transport of b-alanine and tryptophan. Genes required for the
production or transport of BATT will be characterized by RNA interference (RNAi) combined with mass
spectrometry and chemical rescue experiments. In Aim 2, candidate G protein-coupled receptors (GPCRs)
expressed in somatic gonadal cells and germline stem cells will be identified by a combination of single-cell
RNA sequencing and spatial transcriptomics. Potential BATT receptors will be identified by RNAi screening for
knockdowns that phenocopy loss of BATT. Candidate BATT receptor(s) will be validated by cell-based GPCR
assays. The proposed experiments capitalize upon the planarian’s inductive germ cell specification and the
functional genomic tools available for studying these animals to characterize a new signaling pathway. In
addition, this work could provide new approaches for disrupting reproduction in parasitic flatworms, whose
prolific reproductive output enables them to propagate and afflict hundreds of millions of people worldwide.

Public health relevance
Project Narrative Germ cells give rise to the next generation by producing gametes (eggs and sperm); studying how these cells are produced and regulated is relevant to understanding potential causes of infertility in humans and the cancers that result from inappropriate regulation of germ cells or germ cell genes. This research uses the planarian to understand how germ cells develop because it is relatively easy to identify genes and study their functions in this simple animal. In addition, what we learn from studying planarians may be applied to control parasitic flatworms that infect hundreds of millions of people around the world.